Expanding Access to Low-Barrier Buprenorphine in Acute Care Settings Through Enhanced Best Practice Model Fidelity and Prehospital Innovations to Address the Opioid Overdose Crisis

ABSTRACT
Project Title: Expanding Low-Barrier Buprenorphine Initiation and Post-Discharge Engagement in
Emergency and Prehospital Settings
Background: The opioid crisis continues to pose a significant public health challenge, with opioid-
related overdose stubbornly high across the U.S. despite the availability of evidence-based treatment
options. Emergency departments (EDs) and emergency medical services (EMS) serve as critical
intervention points for patients experiencing opioid-related crises. However, despite strong evidence
supporting ED-initiated medication for opioid use disorder (MOUD), implementation remains limited
due to provider hesitancy, institutional barriers, and gaps in post-discharge care. This project seeks to
address these challenges by integrating structured, high-dose buprenorphine induction across EMS
and ED settings while ensuring sustained post-discharge engagement through a multidisciplinary
mobile outreach team.
Objectives: This study will evaluate the impact of a structured MOUD expansion model that spans
prehospital, acute care, and community settings. The primary objectives are to:
1. Increase buprenorphine administration in ED and EMS settings to improve rapid access to MOUD.
2. Enhance provider adoption of high-dose buprenorphine induction protocols through structured
training and technical assistance.
3. Improve patient retention at 7-day and 30-day post-discharge intervals via proactive mobile
outreach and linkage to outpatient treatment.
4. Decrease overall ED utilization among patients receiving buprenorphine, reducing avoidable
healthcare encounters and hospital burden.
Methods: This study employs a mixed-methods evaluation framework, integrating both quantitative
and qualitative assessments. Electronic health records (EHRs) will track buprenorphine
administration rates, help monitor retention in treatment, and measure changes to ED utilization and
hospital re-admissions. Provider surveys and structured interviews will assess confidence and
knowledge in high-dose induction protocols. The ED-IMAT tool will systematically evaluate
institutional readiness, training gaps, and care linkage challenges. Qualitative insights from Extension
for Community Healthcare Outcomes (ECHO) sessions will further inform implementation barriers
and real-time adaptation strategies.
Significance: By embedding a sustainable, data-driven MOUD expansion model within acute and
prehospital care settings, this initiative directly supports Healthy People 2030 objectives to increase
the proportion of individuals receiving MOUD and reduce opioid-related mortality. Findings will
contribute to national efforts to scale ED and EMS-based addiction treatment, inform state and
municipal policy, and establish a replicable framework for integrating MOUD into emergency care
workflows.
Impact: This project aims to transform opioid overdose response by shifting from a reactive to a
proactive, patient-centered model of care. Through structured capacity-building, real-time technical
assistance, and post-discharge navigation, this initiative will optimize MOUD retention, improve health
outcomes, and reduce opioid-related harms at the population level.

Public health relevance
Project Narrative: This project aims to improve access to life-saving treatment for opioid use disorder (OUD) by expanding the use of buprenorphine in emergency and prehospital settings. By training healthcare providers and integrating treatment across EMS, emergency departments, and community-based care, this initiative will help individuals stay in treatment, reduce overdose deaths, and decrease avoidable hospital visits. In the long term, this research will inform national strategies to make addiction care more accessible, ultimately improving public health and saving lives.